Administrative Core

HDFCCC Administration: Summary/Abstract
HDFCCC Administration is responsible for all financial, operational, and program management; strategic
planning and evaluation; and research administrative support of the overall research operations of the
HDFCCC, which ensures research efforts are aligned with the HDFCCC mission and strategic activities.
HDFCCC Administration also oversees and coordinates the allocation and management of space, facilities,
and equipment to support the strategic goals of the HDFCCC and the infrastructure for the CCSG. Under the
management of the Associate Director for Administration, HDFCCC Administration provides support across the
Center to (1) ensure appropriate leadership, staffing, and functional units to support all research-related
activities of the HDFCCC; (2) provide specific CCSG research administration and related activities; and (3)
work within UCSF infrastructure to leverage support, remove administrative barriers, avoid duplication of effort,
and increase efficiency.